DCD as a Model for Developmental Disorders: Compliance Control and Handwriting

DESCRIPTION (provided by applicant): This application requests support for a program of basic and clinical research on Developmental Coordination Disorder (DCD) and sensori-motor learning. The primary objective of this project is to understand how barriers to effective motor learning created by sensori-motor deficits can be overcome to enable children with DCD, and other developmental disorders often co-morbid with DCD, to learn to perform good compliant manual actions and especially, handwriting. The proposed research will involve behavioral studies of sensori-motor learning. Four specific aims will be studied: (1) learning with assistance; (2) generalization from assisted practice and retention; (3) passive versus active practice; and (4) task specific practice. The research findings will provide a much stronger conceptual and theoretical basis for explaining the problems faced by children with DCD and other co-morbid developmental disorders with origins in sensori-motor deficits. The results from this project will also have important direct clinical implications for design of therapeutic training for children with sensori-motor disorders. Furthermore, the results are anticipated to enable future efforts to pursue the developmental effects of sensori-motor deficits on cognitive function and emotional experience. PUBLIC HEALTH RELEVANCE: The objective of this research project is to understand how barriers to effective motor learning created by sensori-motor deficits in Developmental Coordination Disorder (DCD) can be overcome to enable children with DCD, and developmental disorders often co-morbid with DCD, to learn to perform good drawing movements and handwriting. The results will contribute to a theoretical basis for explaining the problems faced by children with DCD with direct implications for the design of therapeutic training for these children.

Public health relevance
The objective of this research project is to understand how barriers to effective motor learning created by sensori-motor deficits in Developmental Coordination Disorder (DCD) can be overcome to enable children with DCD, and developmental disorders often co-morbid with DCD, to learn to perform good drawing movements and handwriting. The results will contribute to a theoretical basis for explaining the problems faced by children with DCD with direct implications for the design of therapeutic training for these children.